Role of Phosphoinositides and Protein Kinases in the control of Cancer Metabolism

Project Summary/Abstract
Previous work funded by this R35 grant led to the discovery that oncogenic viruses stimulate the production of
a set of lipids that were not previously known to exist: phosphatidylinositol-3-phosphate, phosphatidylinositol-
3,4-bisphosphate and phosphatidylinositol-3,4,5-trisphosphate. This led to the discovery of the family of
enzymes that generate these lipids, the phosphoinositide 3-kinases (encoded by the PIK3C family of genes).
Subsequently, the PTEN tumor suppressor gene was shown to dephosphorylate the 3 position of these lipids.
It is now clear that activating mutations in the PIK3CA gene and loss of function mutations in the PTEN gene
are among the most common events driving the growth of cancers. Research funded by this grant revealed
that the lipid products of PI3K directly activate a subset of protein Ser/Thr kinases, most notably the AKT
family, and thereby initiate a set of protein kinase cascades, including activation of the mTOR protein kinase
that coordinates a set of anabolic networks necessary for cell growth. Importantly, this research ultimately
revealed that PI3Kalpha mediates the ability of insulin and IGF1, as well as other growth factors and oncogenic
mutations, to stimulate glucose uptake into tissues.
In order to identify the downstream protein substrates of AKT, mTOR and the host of other protein-Ser/Thr
kinases and protein-Tyr kinases that regulate cell metabolism and cell growth, the funds from this grant were
used to generate a set of oriented synthetic peptide mixtures, 10 residues in length, in which specific amino
acids were locked-in at a specific position and all other positions had a mixture of all 20 amino acids. This
allowed, for each human protein Ser/Thr or Tyr kinase, the identification of the optimal amino acid at each
position, up to 5 residues N-terminal and up to 4 residues C-terminal of the Ser/Thr or Tyr that is
phosphorylated. A manuscript describing the substrate specificity of all the Ser/Thr kinases was published in
Nature this year and a paper describing the substrate specificity of all human Tyr kinases got a favorable
review at Nature and is in revision.
During the next granting period we will utilize the software described in the two Nature papers to determine
what protein kinases are responsible for directly phosphorylating the hundreds of Ser, Thr and Tyr residues
observed on enzymes that mediate anabolic metabolism. By comparing mass spec phosphoproteomics in
cancers to normal tissues this approach will reveal the protein kinase cascades that drive anabolic metabolism
in cancers and reveal new targets for pharmaceutical intervention to prevent survival of tumor cells.

Public health relevance
Project Narrative Protein kinases and lipid kinases have ATP pockets that are druggable and inhibitors of these two families of enzymes have been approved for treating cancers that have activating mutations in genes encoding these protein or lipid kinases. Yet, mass spec phosphoproteomics reveal that many cancers without obvious genetic aberrations in lipid or protein kinases have enhanced phosphorylation and activation of enzymes that drive anabolic processes. The focus of the proposed research is to utilize the software developed during the previous funding period (described above) to determine what protein kinases are likely to be driving growth of cancers based on changes in phosphorylation in the cancer compared to normal tissue and use this information to identify the appropriate protein kinase inhibitor to treat the cancer.